Mechanisms of lens epithelium fibrosis and its relevance to posterior capsule opacification

Abstract
Cataract surgery is associated with a high risk of posterior capsule opacification (PCO), a form of secondary
cataract, the formation of which is still poorly understood. However, PCO is generally considered a chronic
disease and a consequence of the LEC fibrotic process, attributed in part to the epithelial-mesenchymal transition
(EMT) in which TGFβ mediated signaling is one of the key players. Recently, we and others have suggested
that canonical Wnt/β-catenin signaling is also a pivotal player in LEC fibrosis and the pathogenesis of PCO. To
test the Wnt signaling in chronic conditions, we conducted a 6-month-kinetic rabbit cataract surgery study and
found a profound activation of the canonical Wnt signaling during the course of PCO formation, associated with
elevated oxidation and chronic inflammation. We postulate that lens epithelial cells (LECs) undergo self-
regulatory signaling transduction to adapt to the new microenvironment after cataract surgery, and the canonical
Wnt/β-catenin plays a pivotal role in this process. Our initial study identifies Wnt3 as a highly expressed and
upregulated Wnt-family gene in human and mouse LECs after cataract surgery. However, the role of Wnt3
signaling mediated LEC fibrosis and PCO formation is still unclear; the underlying mechanisms of how lens
epithelial cells regulate the Wnt signaling remain to be addressed. We plan to unravel these puzzles with a basis
of support from several key findings of our pilot studies, e.g., our discovery that LECs package Wnt3 into
exosomes, a type of extracellular vesicle (EVs), and conduct signaling transduction in an endocrine fashion.
Importantly, inflammatory cytokines, such as TNFα, can drastically promote exosome biogenesis and Wnt3
secretion. Aim 1 will test how lens epithelial cells regulate Wnt3 packaging and exosome biogenesis. We need
to understand how LECs manage to promote exosome biogenesis and Wnt3 secretion under the certain stimuli,
e.g., inflammatory cytokines and oxidative stress. Aim 2 will delineate the role of Wnt3 in LEC proliferation,
migration, and differentiation using in vitro cell culture, primary cell culture, ex vivo explant culture, and in vivo
mouse models. Aim3 studies the LECs’ growth microenvironment and the Wnt3 mediated autocrine signaling by
using human tissue with and without a history of cataract surgery. Human tissue studies will offer a final
checkpoint of research after studies from cell culture and animal models. In summary, substantial pilot data form
the basis of our proposal, one which will unravel a novel LECs self-regulatory pathway that is closely reminiscent
of the pathological and physiological conditions of cataract surgery.

Public health relevance
PROJECT NARRATIVE Secondary cataract is the most common complication after cataract surgery. This study is intended to understand the fundamental role of inflammation and oxidation in the progression of this complication.